AR Gene Rearrangements and AR Signaling in Prostate Cancer

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PC) is the most frequently diagnosed male cancer. Surgery or radiation therapy are curative
treatments for localized PC while systemic endocrine therapies are standard-of-care for advanced or
metastatic PC. The molecular target of endocrine therapy is the androgen receptor (AR), a transcription factor
activated by the steroid hormones testosterone and dihydrotestosterone. Because PC cells require AR for
proliferation and survival, inhibiting testosterone production (with gonadotropin releasing hormone analogs
and/or abiraterone acetate) and using competitive AR antagonists to block testosterone actions (such as
enzalutamide, apalutamide, and darolutamide) are the cornerstones of endocrine therapy. Unfortunately,
endocrine therapy is not curative and the disease will inevitably progress to advanced castration-resistant PC
(CRPC). CRPC is a lethal disease stage for which no curative therapies exist. Our analysis of tumor
specimens from patients has shown that one of the most frequent alterations occurring in CRPC is structural
rearrangement of the AR gene. Our preliminary data show that AR gene rearrangements uncouple the AR
transcription factor from endocrine regulation and also from negative feedback regulation that occurs when
tumor suppressor genes like PTEN are lost. This uncoupling renders AR activity insensitive to endocrine
therapies and promotes CRPC. The long term goals of this project are to harness AR gene rearrangements as
biomarkers to guide more effective use of current and future CRPC therapeutics, and to develop novel
therapeutics that can overcome the effects of AR gene rearrangements. To achieve these goals, we will
develop new mouse models of CRPC progression that harbor AR gene rearrangements and PTEN loss, and
use these models to identify mechanisms by which AR gene rearrangements promote PC progression and
therapeutic resistance. These models will fill a long-standing void in the field: a lack of mouse models reflecting
clinically-relevant AR alterations. We will test the utility of these models for advancing CRPC research by
evaluating CRPC responses to AR-targeted therapeutics in a whole-organism context. We will also use third-
generation genome structural variation analysis techniques to interrogate the structure of certain AR gene
rearrangements that occur via complex, multi-step mechanisms. This work is expected to provide clarity about
the role and origin of the most frequent and complex patterns of AR gene rearrangements in CRPC. Finally,
therapeutic vulnerabilities of CRPC models harboring AR gene rearrangements will be evaluated using a set of
candidate AR-targeted therapeutics. We will also use computational methods to nominate non-AR-targeted
therapeutics that will have efficacy in CRPC tumors harboring AR gene rearrangements. Collectively, this work
is expected to enhance understanding of AR gene rearrangements in CRPC progression, and yield new
models, biomarkers, and therapeutics that can be used to combat this lethal subset of the disease.

Public health relevance
PROJECT NARRATIVE The majority of prostate cancer mortality is due to failure of endocrine therapies to maintain suppression of androgen receptor activity. The proposed studies are focused on understanding how genome structural alterations in prostate cancer cells promote persistent androgen receptor activity during endocrine therapy. This project will study and model these genome structural alterations to understand their role in supporting endocrine therapy resistance, and develop new therapeutics that eliminate tumor cells harboring these alterations.